Genomic and metabolomic foundations of human-microbial symbiosis in the gut

ABSTRACT
Acute malnutrition (wasting) affects >45M children under the age of 5; two-thirds suffer from moderate acute
malnutrition (MAM) while the remainder have severe acute malnutrition (SAM). Besides accounting for 21% of
life-years lost among children younger than 5 years, undernutrition leads to long term growth impairments,
immune and metabolic dysfunction, and altered CNS development. Current treatments have limited
effectiveness. We found that MAM and SAM are associated with impaired gut microbial community
development (microbiota immaturity). We then screened Bangladeshi complementary foods in gnotobiotic
animals for their capacity to improve the fitness and expressed beneficial functions of key growth-promoting
bacterial taxa underrepresented in the microbiota of children with malnutrition. This yielded a `microbiota-
directed complementary food' formulation (MDCF-2) that in a randomized controlled clinical trial (RCT),
repaired the microbiota of 12-18-month-old Bangladeshi children with MAM and accelerated weight
gain/ameliorated stunting compared to an existing ready-to-use supplementary food (RUSF) that was 15%
more calorically dense. The efficacy of MDCF-2 was confirmed in a second RCT. We identified metabolic
pathways in metagenome-assembled genomes (MAGs) belonging to specific strains of Prevotella copri that
are differentially expressed in response to MDCF-2 and positively associated with growth (weight-for-length Z
score; WLZ); this differential expression was associated with the metabolism of specific glycan structures in
MDCF-2 and with the magnitude of clinical response to treatment. Tests of MDCF-2 derivatives in which single
ingredients were replaced by `glyco-equivalent' food staples, conducted in gnotobiotic mice harboring MAM-
donor microbiota, followed by a pilot translational study in Bangladeshi children with MAM, further highlighted
glycan structures targeting P. copri. We will use 2 specific aims to build on these findings. Aim1-Perform a
pan-genome analysis to define features of P. copri MAGs positively associated with WLZ in our RCTs that are
highly conserved in P. copri strains we culture from Bangladeshi children, and strains obtained from other
countries. Combine in vitro growth assays, microbial RNA-Seq and mass spectrometry to test the effects of
lead glycan structures obtainable at scale singly and in combination, on cultured P. copri strains with
carbohydrate utilization machinery exemplifying the different strains documented in the pan-genome analysis.
Results will identify strains/glycan combinations that approximate the MAG expression profiles observed in our
RCTs and gnotobiotic models and refine selection of prebiotic candidates. Aim2-Use a gnotobiotic mouse
model of intergenerational microbiota transmission to perform mechanistic studies (microbial RNA-Seq/host
bulk and snRNA-Seq/microbial community and host targeted MS-based metabolomics) of the effects of
prebiotic single or combination glycan leads from Aim1 on targeted P. copri strains and on host growth and
expression of metabolic/signaling pathways in intestinal cell lineages distributed along the length of the gut.

Public health relevance
PROJECT NARRATIVE A central premise of this project is that healthy growth of infants and children requires coordinated development of our human organs and of the large community of microbes that inhabit our intestines (the `gut microbiota'). We have (i) found that children with undernutrition - a devastating, pervasive global health challenge - have impaired development of their gut microbial communities, and (ii) developed a microbiota- directed therapeutic food formulation that, in randomized controlled clinical trials conducted in Bangladesh involving 12-18-month undernourished children, repaired their microbiota and produced greater improvements in ponderal and linear growth than a standard nutritional supplement, even though the microbiota-directed food had fewer calories. This project builds on these findings. It describes an approach for marrying microbiome science and human nutrition to select glycan components harvested from the byproduct streams of food manufacture as prebiotics that are able to effectively target a key growth-promoting member of the developing microbiota - one that exhibits strain-level diversity within and between populations. Identifying the bioactive components of a food and characterizing their interactions with their microbial targets has therapeutic implications including (i) improved efficacy based on better knowledge of dosing, (ii) use of prebiotic formulations in lieu of the need to manufacture and distribute shelf-stable therapeutic food formulations; (iii) use of synbiotics (prebiotic and probiotic formulations consisting of the glycans plus their targeted bacterial strains) to treat children who initially fail to respond to treatment with microbiota-directed therapeutic foods and/or lack responsive strains. It also has implications for disease prevention including development of recommendations about the types of complementary foods that should be administered to weaning-age children to ensure healthy development of their gut microbiota.